NE-CAT: A Resource for Advanced Macromolecular Crystallography

The main goal of the NE-CAT Resource is to provide user access to state-of-the-art synchrotron beamlines for
macromolecular crystallography. NE-CAT began planning and design for two beamlines in 2001. Beamline 24-
ID-C became available to the Advanced Photon Source users in 2006 and beamline 24-ID-E became available
in 2007. During the ensuing years, beamline improvements have resulted in ultrastable, small X-ray beams
ideally suited for challenging problems in macromolecular crystallography. Each beamline is equipped with a
high capacity sample automounter and a microdiffractometer. Beamline 24-ID-C features a PILATUS 6MF
pixel array detector, and by early 2017 an EIGER 16M pixel array detector will be available on beamline ID-24-
E. NE-CAT provides automated software for data collection and analysis (RAPD) and a Web-based interface
for remote data collection. We will continue to provide routine maintenance to ensure efficient and reliable data
collection, and we propose an upgrade program to maintain state-of-the-art capabilities over the five years
covered by this application. NE-CAT has an experienced and dedicated scientific staff who enable access to
the beamlines. The staff is available or on call 24/7 to assist users with data collection and processing needs.
This highly regarded staff is a major strength of NE-CAT. NE-CAT has an outstanding record of reliability with
technical problems rarely interfering with user access. NE-CAT is directed by Dr. Steven Ealick, who has more
that 25 years of experience overseeing the operation of synchrotron facilities for macromolecular
crystallography. The technical group, led by Deputy Director Dr. Malcolm Capel, and the operations group, led
by Associate Director Dr. Kanagalaghatta Rajashankar work closely together to ensure that the needs of the
user community are met. Assistant Director Dr. Frank Murphy is responsible for development and maintenance
of RAPD. Together, these four individuals make up the NE-CAT management team. NE-CAT beam time is in
high demand, and each run all available beamtime is allocated to users. NE-CAT typically hosts more than
1500 users per year from about 160 unique user groups, either on site or remotely. NE-CAT users published
about 150 papers during the last year, and they are projected to publish around 170 in 2016. NE-CAT's record
of productivity places us among the top of worldwide facilities for macromolecular crystallography. NE-CAT
operates an extensive user training program adaptable to first time users, advanced users with technically
challenging problems, and everyone in between. A Web site is available to provide all information needed by
new or current users. NE-CAT participates in many training and outreach activities including organization of an
annual workshop and participation in professional society meetings. The staff works closely with user groups
and are often invited to coauthor manuscripts resulting from user assistance.

Public health relevance
The purpose of the proposed Resource is to provide the biomedical community with access to state-of- the-art facilities for macromolecular crystallography. The Resource will enhance our ability to visualize the three-dimensional structures of biological macromolecules. Many of these molecules are targets for drug design, and understanding their structures will aid in the development of new pharmaceutical agents. In addition, these structures allow us to better understand basic biological systems often resulting in the identification of new pharmaceutical targets.